Task A44: Ferret Models for the Evaluation of Universal Influenza Vaccines and Vaccine Strategies

This contract provides for the development and standardization of small animal models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.